Mitochondrial stress promotes immunosuppressive potential of myeloid subsets in tumors

ABSTRACT
The immunosuppressive tumor microenvironment (TME) orchestrated by advanced malignancies represents a
key driver for tumor progression and a challenge for the successful development of curative immunotherapies.
Multiple pro-inflammatory processes active in the TME induce chronic myelopoiesis and subsequent expansion
of highly immunosuppressive myeloid cells, including Myeloid-derived suppressor cells (MDSC) subsets, Tumor-
associated macrophages (TAM), and Dendritic cells (DC). To date, however, the approaches to clinically block
the regulatory effects of myeloid cells in tumors are limited to myelosuppressive agents or inhibitors that are only
partially effective. Thus, alternative strategies to overcome the immunosuppressive and pro-tumorigenic actions
of myeloid cells in cancer are expected to have a significant clinical impact. Infiltration of myeloid cells into tumors
makes them exposed to stress conditions, including hypoxia, nutrient deprivation, and elevated reactive oxygen
and nitrogen species, which trigger overactivation of endoplasmic reticulum (ER) stress. Our recent manuscripts
demonstrated that maladaptive signaling by major arms of the ER stress responses, PERK and Chop, impaired
anti-cancer immunity by intrinsically altering the metabolic and functional activity of myeloid cells in tumor beds.
Notably, our new preliminary results in tumor-infiltrating myeloid cells indicate a potential crosstalk between ER
stress response signals and the activation of mitochondrial unfolded protein response (UPRmt), a process that
ultimately controls mitochondrial homeostasis under stress. Thus, we hypothesize that the chronic overactivation
of PERK→Chop provokes detrimental UPRmt in tumor-linked myeloid cells, which results in a program that allows
mitochondrial adaptation to stress and sustains immune evasion. Also, we postulate that therapeutic targeting
of UPRmt driver LonP1 limits immunosuppressive myelopoiesis, primes protective anti-tumor T cell responses,
and augments the effectiveness of cancer immunotherapy. Thus, proposed studies will unearth for the first time
a mechanistic link between maladaptive ER stress and UPRmt as a central metabolic inhibitory system in tumor-
related myeloid cells, while outlining new strategies to effectively reprogram immunosuppressive myelopoiesis
and to enhance the effects of immunotherapy. We propose the following Specific Aims:
Aim 1. Determine the role of the activation of the PERK→Chop axis in the induction of UPRmt in tumor-associated
myeloid cells.
Aim 2. Elucidate the role of UPRmt driver LonP1 in the regulatory activity of tumor-linked myeloid cells.
Aim 3. Evaluate whether inhibition of LonP1 augments the effectiveness of cellular- and checkpoint-based
immunotherapies in tumor-bearing hosts.

Public health relevance
PROJECT NARRATIVE This proposal will identify an elusive metabolic process centrally governing the immunosuppressive function and expansion of myeloid cells in tumors, which could significantly increase the efficacy of promising approaches for cancer immunotherapy. Specifically, information gathered from this effort is expected to: 1) provide insights into the metabolic signals underlying mitochondrial adaptation and immunoregulatory polarization of myeloid cells in tumors; 2) set the foundation for the development of novel systems to functionally reprogram myelopoiesis in cancer; and 3) boost the effectiveness of immunotherapy by transforming “cold” tumors into “hot” malignancies highly infiltrated by reactive T cells and reprogrammed myeloid cells that sustain anti-tumor activities.